Triaging dolutegravir resistance via a point-of-care urine tenofovir assay

PROJECT SUMMARY/ ABSTRACT
Tenofovir (TFV)-lamivudine-dolutegravir (TLD) has been first line HIV therapy worldwide since 2018. TLD is
also used as second line therapy more recently in those with a history of prior treatment experience. However,
in 2024, there is evidence of increasing rates of dolutegravir (DTG) resistance globally (4-8%), with rates
up to 20% among those with virologic failure and treatment experience. Integrase strand transferase inhibitor
(INSTI) resistance screening worldwide is therefore an urgent global priority, although HIV drug resistance
(HIVDR) is still severely rationed in most low-and-middle-income countries due to cost.
HIVDR is higher among people living with HIV (PWH) with virologic failure and laboratory-confirmed
exposure to ART, demonstrating that high viral loads combined with ART exposure are more likely to signal
HIV drug resistance (HIVDR) due to selective drug pressure from the antiretroviral(s) on the virus to evolve.
The 2023 South Africa treatment guidelines now state HIVDR testing should only be requested after 2 elevated
viral loads on TLD are documented and adherence is established using one of five objective adherence
metrics; 1) a urine assay to detect tenofovir (TFV); 2) DTG levels in plasma; 3) tenofovir-diphosphate (TFV-DP)
levels in dried blood spots (DBS); 4) clinic attendance; 4) pharmacy refill data. Our laboratory group at UCSF
recently developed a point-of-care urine TFV assay that can assess with high accuracy whether TFV was
recently ingested. However, the urine assay has not been rigorously studied for the prediction of resistance in
PWH failing TLD to date. We thereby propose to test the ability of the urine TFV assay to triage HIV drug
resistance testing in South Africa, comparing it to other metrics and assessing cost.
We will first compare the prevalence of DTG resistance among PWH with prior treatment experience
failing TLD with a positive or negative urine TFV assay, with participants recruited from large HIV treatment
clinics in Cape Town and Johannesburg (Aim 1). We will then compare the ability of the urine TFV assay to
predict DTG resistance with other adherence measures (other drug level assays, pharmacy refills, clinic visits)
listed in the South Africa treatment guidelines, hypothesizing that the harder-to-collect metrics (pharmacy
refills/clinic visits) will be less predictive of DTG resistance than the three more precise drug level assays (Aim
2). We will then examine the feasibility and cost-effectiveness of the urine assay in triaging HIVDR testing,
since a scalable, cost-effective tool to determine those at the highest risk of HIVDR is urgently needed.
The urine TFV assay is an exciting point-of-care diagnostic test which has already shown to improve HIV
prevention and treatment outcomes in high burden HIV settings. If the low-cost urine TFV assay (<$2/test) is
found to be highly predictive of HIV drug resistance in our study, the assay should be added to provincial,
national, and international guidelines as a cost-effective, scalable tool to triage HIV drug resistance
testing in this era of increasing concern regarding DTG resistance globally.

Public health relevance
PUBLIC HEALTH RELEVANCE/ PROJECT NARRATIVE Although we now have once-daily fixed-dose combination treatments for HIV with tenofovir-lamivudine- dolutegravir (TLD) globally, it can be difficult to take a pill every day for HIV and virologic suppression rates around the world for those who are on treatment are around 70%; moreover, in 2024, there is increasing concern for the development of resistance to the main drug in the regimen, which is dolutegravir. We developed in our research group a urine-based test that can detect tenofovir at the point-of-care (the test looks like a urine pregnancy test); virologic failure on TLD with tenofovir in the system puts pressure on the virus to evolve resistance to any of the three components of the TLD regimen, including dolutegravir. Since HIV drug resistance testing in low-and-middle-income countries is not done frequently due to high costs, we need an easy-to-perform, low-cost tool like the urine tenofovir assay to determine who is most at risk of resistance and needs testing; this proposal will examine the ability of the urine test to triage HIV resistance screening in South Africa, with the hope that the assay will be listed in the World Health Organization (WHO) HIV guidelines as a screening tool if this grant’s aims are successful.